Targeting the CDK4/6 pathway in MiT/TFE-translocation renal cell carcinoma

PROJECT SUMMARY
Renal cell carcinoma (RCC) is one of the top ten most common cancers worldwide and is comprised of multiple
distinct histologies. One particularly aggressive subtype of RCC is translocation renal cell carcinoma (tRCC), a
devastating and aggressive neoplasm that is defined by a gene fusion involving a transcription factor in the
MiT/TFE gene family, most commonly TFE3. Currently, there are no approved therapeutic agents that are
specifically targeted to the biology of tRCC. In addition, we have an incomplete understanding of how TFE3
fusions drive this cancer, which represents a major unmet medical need. We recently applied genomic discovery
approaches to identify genes and/or pathways that may represent novel therapeutic targets in tRCC. These
studies identified activation of the CDK4/6 pathway as a defining feature of tRCC. CDK4 and CDK6 are kinases
that govern the G1 to S cell cycle transition and thereby promote cell proliferation. Importantly, drugs targeting
these proteins are already FDA-approved for the treatment of certain breast cancers. In this project, we will test
the mechanism-driven therapeutic hypothesis that targeting the CDK4/6 pathway, either alone or in combination
with targeting of the PI3K/mTOR pathway, may be an effective therapeutic strategy in tRCC. In Aim 1, we will
use genetic and pharmacologic approaches to test the sensitivity of tRCC cells to CDK4/6 inhibition in vitro and
in vivo. We will also evaluate genomic, transcriptomic, and proteomic biomarkers of response to CDK4/6
inhibitors in tRCC tumor samples and preclinical models. In Aim 2, we will test the hypothesis that tRCC cells
may be particularly sensitive to inhibition of the Cyclin D-CDK4/6 complex via a combination of CDK4/6 inhibition
and PI3K/mTOR inhibition or mTORC1-selective inhibition, in both in vitro and in vivo models, due to a role for
the latter pathway in stabilizing Cyclin D. This project aims to credential the CDK4/6 pathway in tRCC, which is
an aggressive malignancy and an unmet medical need with no established standard of care. This project will
clarify biomarkers of CDK4/6 pathway activation in tRCC and will also advance a therapeutic hypothesis using
agents that are already approved or in late clinical development. Therefore, this work can be rapidly translated
to design molecularly-inspired clinical trials of CDK4/6 monotherapy and/or combination therapy regimens for
tRCC, which would have the potential to improve clinical outcomes for patients with this devastating cancer.

Public health relevance
PROJECT NARRATIVE Cancer is the second leading cause of death in the United States. Translocation renal cell carcinoma (tRCC) is an aggressive kidney cancer without effective therapies and is an unmet medical need. This project explores whether CDK4/6 signaling may be a defining feature of, and therapeutic vulnerability in, tRCC.